Serial Ultrasound to Detect Early Response to Immunotherapy in Metastatic RCC

Project Summary
We propose a pilot study to detect response to immunotherapy as early as 3 weeks after initiating
therapy, using Doppler ultrasound and contrast-enhanced ultrasound (CEUS) to measure changes in
tumor vascularity in patients with metastatic renal cell carcinoma (mRCC). Biomarkers to rapidly detect
response to RCC therapy are urgently needed, because not all patients respond to first-line treatment with
combined CTLA-4 immune checkpoint inhibitor (ipilimumab) plus anti-PD-1 immune checkpoint inhibitor
(nivolumab). Yet, all patients endure the side effects of this combination treatment (fatigue, autoimmune
hepatitis/thyroiditis/pneumonitis etc.) while awaiting standard-of-care computed tomography (CT) imaging.
Currently, 12 weeks is required to assess response by measuring decreases in tumor diameters with CT because
tumor size does not significantly change before 12 weeks of therapy. Rapid detection of response to RCC therapy
would minimize use of ineffective drugs and allow patients to discontinue ineffective therapies and continue only
effective therapy. We have found that imaging-based measurements of tumor vascularity, such as perfusion CT
scans, can detect early response to therapy in mRCC. But these require potentially nephrotoxic iodine contrast
agents and visits to the radiology department. We have developed highly sensitive, non-contrast, vascular
imaging using advanced power Doppler ultrasound that can be performed at bedside in the oncology clinic to
image vessels as small as 1 mm in diameter. Now, we propose to use advanced power Doppler ultrasound for
a pilot study to assess changes in tumor vascularity, during routine oncology clinic visits for patients receiving
combined therapy, and compare it to conventional power Doppler and contrast-enhanced ultrasound (CEUS,
using non-nephrotoxic micro-/nanobubble contrast agents). We hypothesize that changes in tumor
vascularity, measured by ultrasound, can detect response to treatment earlier than changes in tumor
diameters. We will enroll 30 patients with mRCC, to be evaluated with Doppler ultrasound and CEUS before
treatment and after 3 weeks and 6 weeks of combined ipilimumab and nivolumab therapy. Our pilot study aims
to determine if 1) Doppler ultrasound and/or CEUS can detect changes as early as 3 and/or 6 weeks after
initiating immunotherapy; 2) if changes detected by ultrasound correlate with response measured by standard-
of-care CT scan after 12 weeks of therapy; and 3) which ultrasound time point (3 weeks or 6 weeks) better
anticipates 12-week results. We will use ultrasound imaging to accelerate detection of response to
combined ipilimumab + nivolumab. If successful, we can apply our approach to additional tumors and drugs,
as changes in tumor vascularity are a key mechanism of response to most cancer therapies.

Public health relevance
Project Narrative In patients with metastatic kidney cancer (renal cell carcinoma) treated with nivolumab plus ipilimumab, two immunotherapies, we seek to determine if changes in tumor blood flow, measured with ultrasound before and at 3 weeks and 6 weeks after initiating therapy, can predict response to therapy measured by standard-of-care computed tomography (CT) scans after 3 months of therapy. This would allow to discontinue ineffective treatment earlier in patients who do not respond to treatment, and who currently have to wait 3 months until a CT scan shows that the immunotherapy is not working.